Kentucky Center for Clinical and Translational Science

The University of Kentucky (UK) Center for Clinical and Translational Science (CCTS) has created an integrated home for clinical and translational research which promotes scientific progress and discoveries at every phase of the translational continuum. The CCTS has partnered with communities in Central Appalachia to address multiple generations of recalcitrant health challenges related in part to the economic distress of rural communities. The CCTS has fundamentally transformed UK and Central Appalachia through the development of strong academic-community research networks and collaborations within the CTSA consortium. Appalachia faces stunning health liabilities further magnified by the opioid and substance abuse epidemic, which has greatly impacted eastern Kentucky and West Virginia. The strong UK research portfolio puts the UK CCTS in an optimal position to lead local, regional and national research efforts focused on rural health challenges. The aligned missions of UK, UK HealthCare and the CCTS focus on achieving health for all in Kentucky and require engaging in highly innovative, collaborative and dynamic translational research to address rural health needs. The CCTS will continue to educate the translational workforce of the future, engage rural communities in translational and bi-directional team science and work with the national network to advance transdisciplinary research and clinical trials through the following Specific Aims: 1) develop, innovate and transform our research environment to promote impactful science and discovery within our integrated health care system to meet the unique health needs of Central Appalachian residents; 2) lead institutional innovation in the delivery of impactful clinical and translational research that covers the lifespan, fully engages the community and embraces team science; 3) catalyze an efficient, university-wide clinical trials organization which adds value to the CTSA consortium by engaging participants from rural Central Appalachia; and 4) foster and enhance a workforce characterized by representation across all translational science disciplines and populations. The UK CTSA hub is uniquely positioned in the National CTSA Consortium to foster novel technologies, team science, clinical trial start-up and cutting-edge translational research across the lifespan with a focus on rural communities. We have a particular focus on the Central Appalachian community, a rural area that reflects many of the most pressing health concerns of the nation. This focus will ultimately elevate the health and quality of life of rural communities throughout the United States

Public health relevance
The UK CTSA program hub is uniquely positioned in the National CTSA Consortium to foster novel technologies, team science, clinical trial start-up and cutting-edge translational research across the lifespan. Our UK CTSA hub has a significant presence on the national stage. Our focus on the Central Appalachian community, a rural region with many of the highest priority health concerns of the nation (i.e., cardiovascular, neuroscience, cancer, obesity/diabetes), including as an epicenter for the opioid and substance use epidemic, distinguishes our mission and activities. The programs in this proposal will ultimately elevate the health and quality of life for people of this region and provide a national model for rural populations facing challenges in access to care.